Chemistry-Biology Interface Training Program

PROJECT SUMMARY/ABSTRACT The mission of the UW–Madison CBIT program is (i) to train graduate students to recognize and address problems that transcend the traditional boundaries of chemistry and biology using innovative and rigorous approaches, (ii) to provide professional development skills and career guidance that maximize the impact of student training, and (iii) to develop an inclusive and supportive community of engaged scholars working at the chemistry?biology interface. This renewal application requests support for 10 predoctoral trainees per year, with each trainee appointed to the program for two years. Key themes are underscored below: • Our CBIT program will help train the next generation of the biomedical research workforce. We seek to provide cross-disciplinary research training to our students, so that biologists not only appreciate, but also use, the tools and techniques developed by chemists, and vice versa. It is these fresh approaches that can provide breakthroughs in science. We will provide students with foundational course work in chemical biology and teach our students the value of looking at research problems from alternate perspectives. • We will give our students the professional skills to maximize their cross-disciplinary training in the laboratory. These professional tools will include guidance in scientific communication to diverse audiences, the responsible conduct of research, the rigorous analysis of scientific data, and career opportunities beyond academia. We then will provide opportunities for the trainees to advance their careers through the application of these tools, through outreach, an internship, and scientific conferences. • We will build an engaged and inclusive community of scientists working at the chemistry?biology interface. Through regular interactions with trainees and trainers, we will leverage the strong interactions between faculty/departments on campus and create new scientific collaborations. In turn, we will build strong mentor/mentee relationships between our cohort of students and faculty via formal training in mentorship. • We understand that a diversity of experience enriches the research enterprise. Throughout the pursuit of the CBIT program’s goals, we will fully commit to the inclusion of qualified students from all backgrounds. The outcome of the UW–Madison CBIT program will be a diverse pool of expertly trained scientists who have the broad base of technical and professional skills necessary for them to contribute substantively to the biomedical workforce. With this request for supplemental funds to enhance program evaluation capacity (NOT-GM-20-020), we will (1) establish a working group of campus NIGMS-funded T32 representatives that will work in coordination with UW–Madison program evaluation experts to both create a quantitative tool for evaluating training program efficacy and implement this tool across all NIGMS-funded T32s, (2) expand assessment to all UW– Madison T32s, and (3) disseminate the results of our effort to campus leadership and NIH.

Public health relevance
PROJECT NARRATIVE The Chemistry-Biology Interface Training (CBIT) Program is a unique graduate training program at the University of Wisconsin–Madison centered on an appreciation of the blending of chemical and biological methods to solve biomedical problems. The mission of the CBIT Program is to train graduate students to address research problems that transcend the traditional boundaries of chemistry and biology using innovative and rigorous approaches, to provide professional development skills and career guidance to maximize the impact of their training, and to develop an inclusive and supportive community of engaged scholars working at the chemistry-biology interface. With supplementary funds (NOT-GM-20-020), we will develop assessment instruments to facilitate a transition from our current largely qualitative program assessments to more rigorous, quantitative assessments of our program components. This work will benefit not only CBIT, but also other T32 programs at the University of Wisconsin–Madison and beyond.